Development of in vivo quantitative stable isotope probing to quantify microbiome dynamics in Alzheimers Disease

ABSTRACT
Alzheimer’s Disease (AD) is the leading cause of dementia in the aging population and severely
impacts patient’s and caretaker’s quality of life. Despite decades of research, the underlying etiology of
AD is incompletely understood. The prevailing hypothesis for AD pathology is the amyloid cascade
hypothesis, which posits that the causative agent of AD is the accumulation of amyloid-β (Aβ, the main
component of plaques) in the brain. However, recent Phase III clinical trials that target Aβ have not led
to significant improvements in cognitive function, despite reducing overall brain Aβ burden. There has
been a growing interest in understanding additional pathological features of AD that may impact
disease progression. Recent studies in humans and in mice have suggested a role for pathogenic
microbes or altered microbiota in neuroinflammation and AD. Microbiota in the GI tract can influence
neurological health through microbial production of neurotransmitter precursors, immune-modulatory
metabolites (e.g. short chain fatty acids), or interaction with the vagus nerve or enteric nervous system.
Gut microbiota can also produce amyloids (aggregated, insoluble proteins exhibiting β-pleated sheet
structures) that may cross the blood-brain barrier. Despite growing efforts to understand the gut
microbiome-brain axis, current technologies using DNA or RNA amplicon sequencing are unable to
address fundamental ecological questions, such as quantifying taxon-specific growth rates of host-
associated microbiota. Understanding microbial ecosystem dynamics has large implications for human
disease; quantifying growth or turnover of species in terms of absolute abundance change over time in
an ecosystem can enable predictions of interspecies competition or trajectories of microbial succession
in early and late life, which are associated with host health or disease risk. In this study, we will adapt
an innovative technique widely used in soil microbial ecology to study host-microbiome dynamics in AD.
We will use quantitative stable isotope probing (qSIP), a technique that uses an isotopically enriched
substrate (e.g. 18O-water) to measure gut microbiome dynamics in triple transgenic (3xTg-AD) and wild-
type mice. Since H2O is a universal substrate, labeled 18O will incorporate into microbial and host
biomolecules, including nucleic acids; this feature allows a researcher to separate extracted DNA by
density to quantify taxon-specific growth rates. Completion of this study will lead to the development of
a novel tool that can be widely used in the AD community to better understand the contribution of host-
associated microbiota to AD progression and neuroinflammation.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease, characterized by amyloid deposits and neurofibrillary tangles, is the most common form of dementia in the aging population. The gastrointestinal (GI) microbiota may contribute to neurodegeneration through various mechanisms, including increasing neuroinflammation, but gut-associated microbial communities are not well understood in Alzheimer’s Disease. We adapt a novel technology that is widely used in environmental microbiome sciences, quantitative stable isotope probing (qSIP), to further understand gut microbiome dynamics and relationship to Alzheimer’s disease progression and neuroinflammation.